EVALUATION OF SUBCUTANEOUS RHUIL-10 IN MILD-MODERATE ULCERATIVE COLITIS

The primary purpose of this study is to determine the safety and tolerance of multiple doses of Interleukin 10 in patients with ulcerative colitis.